EFFECTIVENESS OF ROBOT-ASSISTED HAND MOVEMENT TRAINING AFTER STROKE

Project Summary/Abstract
The broad, long-term, scientific objective of this project is to identify the behavioral and neural factors that
determine the efficacy of robotic hand movement training after stroke. An important societal impact of achieving
this objective will be the design of more effective robotic rehabilitation exercise technology, which will allow
people with a stroke to increase their movement recovery beyond that possible with current approaches. In our
previous grant, we found that participants with impaired finger proprioception (quantified robotically with a novel
protocol) did not achieve a functional benefit from robotic finger training. Reduced benefit also correlated with
injury to and abnormal activation of the somatosensory system. Our working hypothesis is that finger
proprioceptive integrity is a gateway for robotic assistance because it allows such assistance to stimulate a
Hebbian-like learning mechanism. Building on this “Hebbian Hypothesis”, we add two other hypotheses:
improving proprioceptive capacity with targeted training for those with impaired proprioception will enhance the
effectiveness of subsequent robotic finger training, and proprioceptive integrity modulates spontaneous self-
training outside of formal training. We will test these hypotheses in a series of experiments with a novel robotic
finger training device (“FINGER”) that assists participants in making different grips to play notes in a musical
computer game similar to Guitar Hero. We will recruit participants with hand movement deficits at least six
months after stroke and randomize the participants with intact finger proprioception to participate in Aim 1, and
those with impaired finger proprioception to participate in Aim 2. Aim 1 is to identify the magnitude of the Hebbian
benefit from robot-assisted movement training. Robotic assistance enhances proprioceptive input, but it typically
also enhances reward, because it increases task success. We will determine the magnitude of the benefit of the
enhanced proprioceptive input, beyond the benefit due to enhanced reward. Aim 2 is to determine the extent to
which finger proprioception can be improved through targeted robotic proprioceptive training, and thereby
enhance response to subsequent robotic finger movement training. Aim 3 is to identify mathematical models that
predict the response to the different forms of training experienced by the participants in Aim 1 and 2. The model
inputs will be baseline behavioral and demographic measures, lesion overlap with sensory and motor structures
(via anatomical MRI), and activation of sensory-motor networks (via fMRI and EEG). We aim to provide further
insight into the high variance in robotic training response, and determine who responds best to proprioceptive
training. Aim 4 is to identify the role of impaired proprioception in decreasing spontaneous hand use in daily life
using a novel wearable sensor, because hand use outside of robotic therapy sessions likely exerts a powerful
training effect. Testing of these hypotheses will provide insight into how to manipulate the unique resources for
sensory motor plasticity that each patient retains using robot-based movement training.

Public health relevance
Project Narrative This project will determine how to improve hand movement recovery after stroke, providing people with stroke new ways to access effective, semi-autonomous rehabilitation training using robotic devices. It will also identify people with stroke who are most likely to benefit from robot-assisted movement training.